Training Program in Basic and Translational Cardiovascular Science

ABSTRACT
This is a renewal application of a training program in its 15th year that seeks funding to support the same
number of predoctoral (5) and postdoctoral (3) research trainees as in the prior cycle, in a multidisciplinary
research program in cardiovascular and vascular diseases, spanning from molecular and cellular studies,
multimodal imaging, biomedical engineering, to translational science. During the last funding cycle, we have
been highly successful in expanding our training program from 40 faculty five years ago to 45 faculty in this
competing renewal. The faculty in our Training Program are from five different schools/Colleges. Indeed, the
training program has had a highly synergistic impact on our institution; we have been successful in establishing
a new Cardiovascular Research Institute (CVRI) through institutional funding from five different schools and
colleges at UC Davis, which was launched in the Fall of 2017. The curriculum and activities developed within
the training program have served as models for other training programs in translational research on campus
and hence, serve a wider group of trainees at UC Davis.
The Program operates under the auspices of the Department of Internal Medicine and the Graduate Studies in
Molecular, Cellular and Integrative Physiology (MCIP), Pharmacology and Toxicology (PTX), Biochemistry,
Molecular, Cellular and Developmental Biology (BMCDB), Biophysics (BPH), Biomedical Engineering (BME),
and Applied Mathematics (APM), a truly multidisciplinary program. The goal is to produce a new blend of
scientists who are poised to exchange ideas, expertise, and techniques, leading to the direct and effective flow
and translation of basic science discoveries into clinical testing and applications, as well as generate
mechanistic hypotheses that can be tested at the basic cellular level, directly derived from clinical research.
The advantages of such an integrated program are vast and far-reaching. By merging basic, translational, and
clinical trainees, our objective is to produce scientists, who are not only capable of establishing independent
research, but are also adept at recognizing and integrating relevant, basic science questions/problems into
clinically germane answers and solutions, and vice versa.

Public health relevance
Project Narrative This goal of the Training Program is to produce a new blend of scientists in cardiovascular research who are poised to exchange ideas, expertise, and techniques leading to the direct and effective flow and translation of basic science discoveries into clinical testing and applications, as well as generate mechanistic hypotheses that can be tested at the basic cellular level, directly derived from clinical research.